BIOINFORMATICS

The Bioinformatics Facility provides Cancer Center researchers with computational and informatics tools, such as commercial and in-house developed databases, software packages, high-performance computational clusters, servers, and workstations. The hardware and software resources are available to the end-users of the facility 24-hours-a-day, seven-days-a-week. The staff of the facility provides consultations for utilization of molecular modeling techniques, bioinformatics and biomedical informatics tools and methods, participates in collaborative research, and teaches bioinformatics-related disciplines. The staff of the facility develops and supports cancer-specific registries, and deploys the cancer Biomedical Informatics Grid (caBIG™) infrastructure and tools. In addition, the facility staff educates investigators on the requirements, standards and approaches that enhance data collection, management, mining, and sharing.